Targeting Protein Arginine Methyltransferases to Eradicate Acute Myeloid Leukemia

Project Summary
Treatment outcomes for patients with acute myeloid leukemia (AML) have continued to lag behind outcomes
reported for other hematological malignancies like acute lymphoblastic leukemia (ALL), in part because of the
relatively slow development of immunotherapy (including immune checkpoint inhibitors [ICI]) compared with ALL.
However, translation of currently available immunotherapies to AML treatment has been challenging, and novel
AML-targeting drugs with immune-stimulating activity are greatly needed. The cGAS-STING signaling is a major
pathway that promotes an extrinsic type I Interferon (IFN-I) response, which potently primes T cells in “immune-
cold” cancers, including AML. My laboratory has been active in defining the function of protein arginine
methyltransferases (PRMTs) in leukemia. Herein, our preliminary studies on the basis of primary AML cells as
well as murine AML models reveal an anti-AML immune activation seen after inhibition of PRMT9, a most
recently defined PRMT. Specifically, PRMT9 inhibition stimulated leukemia-intrinsic cGAS, as evidenced by
cGAMP (an immunotransmitter) production, and induced a leukemia-eliminating IFN-I response in murine AML-
microenvironment (ME). When combined with an ICI (PD1 inhibitor), the in-house PRMT9 inhibitor LD2
eradicated AML in animal models. Thus, we hypothesize that PRMT9 activity allows AML cells to evade immune
surveillance by repressing cGAS-STING activity in the ME, and that LD2, alone or combined with an ICI (PD1
inhibitor), elicits T cell activity to eliminate AML cells. Extracellular cGAMP, which is hydrolyzed by ENPP1, and
STING activation in host immune cells, are reportedly essential for immunity. Thus, in Aim 1, using two AML
transplant models, we will determine whether downregulating cGAMP (via either ENPP1-overexpression or
cGAS-knockout (KO) in AML cells) or STING-KO in the immune cell compartment of recipient mice would reverse
PRMT9 inhibition-induced AML regression. In Aim 2, we will determine the mechanisms underlying cancer-
intrinsic cGAS activation seen after PRMT9 inhibition. Specifically, we will define PRMT9 targets that when
unmethylated underlie cGAS activation. In Aim 3, we will assess anti-AML activity of LD2 alone or combined with
a PD1 inhibitor, using AML mouse models. Moreover, to define potential shifts in immune cell types/states after
PRMT9 inhibition, we will perform single-cell transcriptome analysis on AML PDX cells from humanized mouse
treated with LD2 or the combination. We are the first to identify PRMT9 as a druggable immune activation target
against cancer. If successful, this work would support combining a PRMT9 inhibitor with ICIs as a therapy for
AML, in which single ICI therapy has very limited effects.

Public health relevance
Project Narrative Overall outcome for patients with acute myeloid leukemia (AML) remains unfavorable. The limited applicability of allogeneic hematopoietic stem cell transplantation (allo-HSCT) as well as the rise of the immunotherapy era highlights a pressing need to develop novel immune-stimulating drugs for AML eradication. To address this challenge, herein, we will determine whether targeting PRMT9 promotes a sustained leukemia-eliminating immunity and assess whether a PRMT9 inhibitor combined with an immune checkpoint inhibitor eliminates AML cells in-vivo.